Eukaryotic Gene Regulation (EGR) Predoctoral Training Program

PROJECT SUMMARY
The Penn State ‘Eukaryotic Gene Regulation (EGR) Predoctoral Training Program’ will train a future generation
of scientists in experimental, molecular and computational sciences applied towards understanding mechanisms
of eukaryotic gene regulation. The training program will build upon established graduate programs in
biochemistry, molecular, cellular and developmental biology, bioinformatics and genomics. The goals of the EGR
program are consistent with the Cellular, Biochemical and Molecular Sciences (CMB) program at National
Institute of General Medicine. The program aims to cultivate interdisciplinary study and the training of new
scientists pertaining to biological problems and cellular and molecular sciences to advance science and improve
health. Nearly all aspects of biology and human disease are rooted in gene regulation. Our knowledge and
abilities to understand, control, and rectify gene expression and mis-expression is fundamental to the basic
knowledge cells and to the basic knowledge of medicine. A recent report from the American Cancer Society finds
that we are winning the war on cancer in part because of our understanding of fundamental mechanisms of gene
control. However, it is also clear that we must keep up the fight. This fight will require scientists cross-trained in
experimental and computational sciences. The proposed EGR training program will train a diverse cohort of
student-scientists to have critical expertise in biophysics, biochemistry, molecular biology, genetics,
computational biology, and statistics to address fundamental questions in gene regulation. The program will be
anchored within the Center for Eukaryotic Gene Regulation (CEGR), which has been chartered to these
principles for over 20 years. Penn State’s CEGR has a long-standing reputation for producing outstanding
science. This training program will connect and further develop five established graduate programs: Biochemistry
and Molecular Biology (BMMB), Chemistry (CHEM), Chemical Engineering (CHE), Molecular Cellular and
Integrative Biosciences (MCIBS), and Bioinformatics and Genomics (MCIBS-BG). Combining NIH and Penn
State support, the EGR program plans to train a minimum of 13 predoctoral students over a period of five years.
Each trainee will be supported for the two years of their training (year 2 and 3) while receiving foundational
training in EGR. Trainees will gain a thorough understanding of the scientific process, responsible conduct in
science, fluency in innovative research methodologies, ability to utilize genomics and statistical tools in
advancing genome-wide experimental approaches, excellence in cross-disciplinary communication, and
leadership in cross-disciplinary research teams.

Public health relevance
PROJECT NARRATIVE Nearly all aspects of biology and human disease are rooted in gene regulation. Our knowledge and abilities to understand, control, and rectify gene expression and mis-expression is fundamental to basic biological knowledge and medicine. We propose a new predoctoral training program to prepare a cadre of young scientists that excel in cross-disciplinary skills and address fundamental questions related to gene regulation processes and their impact on human health.